Identification and characterization of the CD31-ApoE-mCRP pathway for Alzheimer's disease in humans.

SUMMARY
Our study discovered that elevated blood C-reactive protein (CRP) in Apolipoprotein E4 (ApoE4)
carriers, but not in carriers of ApoE2 and ApoE3 alleles, increased the risk and shortened latency for
Alzheimer’s disease (AD) onset (Tao et al. 2018). As both peripheral chronic inflammation and
peripheral vascular disease increase AD risk, CRP is considered to be the major inflammatory response
protein that mediates toxicity in peripheral vascular injuries/diseases through vascular endothelial cells.
There are two species of CRP, pentameric oligoprotein (pCRP) and monomeric CRP (mCRP). Our
preclinical study discovered that the receptor for mCRP, CD31 (Pecam1), is located on the blood-facing
endothelial cells of the blood-brain barrier (BBB) and that mCRP acts to increase phosphorylation of
the endothelial CD31 receptor (pCD31), transmitting signals and AD pathology in a pattern of
ApoE4>ApoE3>ApoE2 (Zhang et al. 2021). However, whether mCRP is linked with cerebrovascular
endothelial pathology leading to AD risk in humans is unclear. Our central hypothesis is that the
mCRP-CD31 binding on brain endothelial cells will be associated with increased CD31
phosphorylation (pCD31) and neuroinflammation, with more severe cerebrovascular and AD
pathologies, and with cognitive decline in an ApoE sensitive manner (ApoE4 > ApoE3 > ApoE2)
in humans; this pathological process is counter acted by the ApoE-CD31 binding on endothelial
cells in the brain. There are three aims. Aim 1 will establish the relationship between endothelial CD31
expression, CD31 phosphorylation and mCRP to AD risk in ApoE4 carriers using human brain tissues.
Aim 2 will relate brain cerebrovascular expression of CD31, pCD31, and mCRP-CD31 and ApoE-CD31
bindings to incident cognitive change. Aim 3 will isolate microvessels from frozen brain tissues in each
pathology group and apply phosphor-proteomics. We will further validate CD31 and its involved
pathway(s) by using ApoE knock-in mice responding to peripheral elevated mCRP. Should our
proposed study support the concept that mCRP through mCRP-CD31 vs. ApoE-CD31 binding is a
mediating factor of ApoE4 to increase AD risk, it will lay foundation for a new, genetic based drug target
for AD.

Public health relevance
Project Narrative Whether peripheral chronic inflammation through monomeric C-reactive protein (mCRP) is linked with cerebrovasculature pathology leading to Alzheimer’s disease (AD) risk in Apolipoprotein E4 (ApoE4) carriers is unclear. As our preclinical study discovered that the receptor for mCRP, CD31 (Pecam1), is located on the blood-facing endothelial cells of the blood-brain barrier (BBB) in ApoE knock-in mice, the significance of the proposed study is to use human brain tissues and cognitive data when they were alive to further characterize CD31-mCRP vs. CD31-ApoE bindings and their associations with brain pathologies and cognitive changes across ApoE genotypes. Because elderly patients often suffer from inflammatory diseases that are accompanied by consequent elevated CRP levels and releasing of mCRP, this study may lead to effective treatments and risk reduction strategies for ApoE4 carriers.